Core--Clinical

The Clinical Core is an essential component of this grant. The Clinical Core will have two basic responsibilities. 1) The first is the extraction and inputting of data into the DeKAF database, both clinical data from the study sites, and inclusion of genotyping results from the Genotyping Core. This will also include maintenance of the database as it applies to this project and quality control of the data, sample tracking and assurance of HIPPA compliance. It should be noted that the majority of the clinical outcome data will come from the DeKAF project, but additional data will be collected. 2) The second will be to provide statistical support to the two projects, including reports for Projects by Israni and Jacobson.